P30 Core Grant for Vision Research

Overall - Project Summary
The broad goal of this proposal is to provide core support services for 16 Participating Investigators and over
40 Associate Investigators to: (1) enhance the quality and quantity of their research; (2) facilitate collaborations
between investigators with different backgrounds and skills; and (3) recruit new investigators to vision
research, help young vision investigators establish their labs, and allow established investigators to explore
new directions. The Participating Investigators hold 18 qualifying R01 research grants from the National Eye
Institute. The Associate Investigators study vision but do not currently hold a qualifying R01 grant from the NEI.
Collectively, the investigators represent a broad range of vision research, and include experts on animal
models of retinal degeneration, retinal circuitry, gene therapy, cell and molecular biology, molecular genetics,
eye, central visual pathways and cortical physiology, visual performance and cortical function in awake-
behaving primates, cognitive neuroscience of vision, computational modeling, and visual psychophysics. The
core grant will support 4 resource/service modules: Biostatistics provides expert assistance in experimental
design and data analysis, particularly for clinical studies, as well as bioinformatics support; Imaging and
Electrophysiology provides vision investigators access to shared equipment and technical support for a
variety of imaging modalities and electrophysiological recording, including conventional and two-photon
confocal microscopy, multi-electrode array recording from in vitro tissue, and spectral OCT imaging;
Instrumentation provides for design and construction of custom stimulus delivery, data acquisition, and
electrophysiological instruments that are unavailable from commercial sources, as well as maintenance and
repair of such instruments; Scientific Transparency develops novel software tools for pre-processing,
analysis, and presentation of imaging data, and supports data curation and analysis reproducibility.

Public health relevance
Overall - Project Narrative This core grant facilitates the research programs of scientists studying vision at the University of Pennsylvania. These scientists conduct research that reveals the mechanisms of healthy vision, characterizes how disease affects these mechanisms, and uses the insights gained from the basic research to develop sight-saving and sight-restoring treatments. Because it provides support for the entire research chain, this core grant contributes to public health by helping to reduce vision loss.